The Roles of Cby1L and ciBAR1 in Spermatogenesis

Project Summary
The sperm flagellum is a modified motile cilium that is essential for locomotion and fertilization of the egg. As
such, defective flagellogenesis is linked to infertility. Although not completely equivalent, similar mechanisms are
thought to operate during flagellogenesis and ciliogenesis. Defects in ciliogenesis are associated with human
disorders, known as ciliopathies, such as primary ciliary dyskinesia, and many of the patients also present with
fertility issues. Despite tremendous research efforts to understand the role of ciliary proteins in these diseases,
their physiological roles in male fertility remain poorly defined. We reported that mice lacking the critical ciliary
protein Chibby 1 (Cby1) display signs of classical ciliopathies. Molecularly, Cby1 interacts with the membrane
binding Bin/Amphiphysin/Rvs (BAR) domain proteins, Cby1-interacting BAR domain-containing 1 and 2 (ciBAR1
and 2, formerly known as FAM92A and B), to facilitate ciliogenesis. More recently, we found that the Chibby
family member, Cby1-Like (Cby1L, also known as Cby3), is expressed abundantly and almost exclusively in the
testis. I found that Cby1L and ciBAR1 localize to the annulus, a septin-based ring structure on the flagellum, in
the testis. Both Cby1L-/- and ciBAR1-/- male mice are infertile with the majority of sperm showing kinked tails. In
addition, I found that Cby1L physically interacts with ciBAR1 and the annulus septin SEPT4. Interestingly, in the
absence of Cby1L or ciBAR1, the annulus is present but fails to stop at the midpiece/principal piece (MP/PP)
junction and progresses posteriorly into the PP. These data suggest that Cby1L and ciBAR1 form a complex that
assists in proper positioning of the annulus at the MP/PP junction. Although the annulus is typically bound to
membranes during migration, in Cby1L-/- testis, the annulus is partially detached from the flagellar membrane,
suggesting that Cby1L is involved in anchoring the annulus to the membrane. Collectively, my preliminary data
suggest a working model in which a complex of Cby1L and ciBAR1 plays an indispensable role in the accurate
positioning of the annulus at the MP/PP junction. The overall goal of this proposal is to understand the
molecular roles of Cby1L and ciBAR1 in spermatogenesis and annulus positioning. To achieve this goal,
I propose the following Specific Aims: 1, Define the role of Cby1L in flagellogenesis and annulus migration. I will
determine the subcellular localization of Cby1L during spermatogenesis and investigate the molecular and
cellular basis of the male infertility of Cby1L-/- mice. 2, Investigate Cby1L/ciBAR1/septin interactions and
ciBAR1’s role in sperm tail segmentation. I predict that Cby1L forms a complex with ciBAR1 and annulus septins
to mediate the attachment of the annulus to the flagellar membrane, which contributes to the proper
compartmentalization of the sperm tail. In parallel, I will determine the cause of male infertility in ciBAR1-/- male
mice. Overall, I expect that my proposed research will unravel a novel mechanism for the proper positioning of
the annulus, by ciliary proteins, which contributes to proper sperm tail segmentation.

Public health relevance
Project Narrative Infertility is a public health issue, affecting approximately 15% of all couples, and, in about 50% of cases, a male factor is involved. The sperm flagellum is responsible for sperm motility and fertilization of the egg, but how flagella are properly formed remains poorly understood. My research focuses on understanding the roles of the Chibby (Cby) family member Cby1-Like (Cby1L) and Cby1 interacting BAR domain containing protein 1 (ciBAR1) in the formation and function of sperm flagella, thereby contributing to our better understanding of male germ cell development.